PHARMACOLOGICAL ANALYSIS OF IONIC BALANCE IN HAIR CELLS

The purpose of this five-year Institutional National Research Service Award is to provide funding for five predoctoral trainees and four postdoctoral trainees per year to prepare them for academic-research careers in the Speech and Hearing Sciences. Because of the multidisciplinary nature of the scientific substrates underlying Communication Sciences and Disorders, the 15 participating faculty for this training grant are drawn from five different departments in three colleges. Each faculty member has agreed to serve as a research preceptor to one or more trainee supported from this grant during a five-year period of time. Faculty members were chosen for participation on this training grant on the basis of the nature of their ongoing research activities, research funding, and experience in supervising doctoral and postdoctoral students in the speech and hearing sciences. Predoctoral and postdoctoral trainee-are selected on the basis of outstanding credentials that reflect a bonafide potential for productive research careers in the Speech and Hearing Sciences. Funding is requested to provide trainees selected for this training grant up to a maximum of three years of support at either the predoctoral or postdoctoral level.